Inflammation Resolving Lipid Mediators: Novel Therapy for Alcohol AssociatedLiver Disease

Alcohol-associated liver disease (ALD) is a major health problem in the US (especially in the Veteran
population) and alcohol abuse/ALD has increased dramatically during the COVID pandemic. In spite of the
magnitude of this problem, there is no FDA-approved therapy for any stage of ALD. In addition, the mechanisms
and regulators of disease progression and severity are incompletely understood. Dietary fats play an important
interactive role with alcohol consumption in ALD pathogenesis, however, the role of specific n3 polyunsaturated
fatty acids (PUFAs) in ALD are not well defined. Our central hypothesis is that n3 PUFAs are beneficial in
ALD, in part, via n3-PUFA-derived pro-resolving mediators, which facilitate inflammation resolution,
improvement in the gut-liver axis, and subsequent attenuation of liver injury. We propose that n3 PUFA-
derived resolvin D1 (RvD1) is a potential therapeutic agent in ALD acting via RvD1-FPR2-NEAT1 signaling to
suppress pro-inflammatory cytokines and to promote repair of hepatocellular damage, in part, via enhancement
of pro-restorative macrophages. We postulate that compromised inflammation resolution due to impaired RvD1
production/signaling is a critical nutritional factor contributing to the progression and severity of ALD/alcohol-
associated hepatitis (AH) in humans. The Specific Aims of the proposal are: Aim 1: determine the role and
molecular mechanism(s) underlying n3 PUFA and RvD1 beneficial effects in EtOH-induced liver injury and
resolution of inflammation associated with ALD. We will determine whether beneficial effects occur through an
increase in n3-PUFA-derived specialized pro-resolving mediators (SPMs), and RvD1-FPR2 and Neat1-mediated
suppression of pro-inflammatory cytokine signaling and reprogramming pro-inflammatory macrophages to a pro-
restorative phenotype. Wild Type (WT), Fpr2-/-, Neat1-/-, and transgenic fat-1 mice (which are able to
endogenously convert n6 to n3 PUFAs) will be used in this Aim. Aim 2: examine the role n3-PUFAs and RvD1
in maintaining gut barrier integrity, and in the resolution of intestinal inflammation in experimental ALD. We will:
i) test in vivo, in animal models, and in vitro, in intestinal organoid culture, whether n3 PUFAs or RvD1 improve
intestinal barrier damage by attenuating intestinal immune dysregulation; ii) test in vivo whether disruption of the
RvD1-FPR2 axis exacerbates, while blocking Neat1 signaling attenuates, intestinal inflammation and alterations
in the gut barrier integrity; and iii) determine the contribution of the gut microbiota to the beneficial effects of n3
PUFAs and RvD1 in experimental ALD. Aim 3: translate and extend our findings in animal models to human
ALD. Utilizing human samples obtained from Veteran AH patients, we will: i) examine plasma SPM levels and
correlate plasma SPM levels with markers of liver injury, systemic inflammation, and intestinal permeability; ii)
evaluate basal and LPS-inducible SPM production in whole blood (ex-vivo system) and blood monocytes; and
iii) test whether RvD1 improves the phagocytosis/efferocytosis capacity of blood monocytes, and determine if
disruption of the RvD1-FPR2 axis will enhance, while silencing of NEAT1 will decrease, pro-inflammatory
cytokine expression in human monocytes. These three aims will define both untested novel mechanisms for ALD
initiation/progression as well as potential novel therapy that could be rapidly initiated for Veterans with ALD.

Public health relevance
Alcohol abuse exacts a major toll on health and health costs in Veterans. Even though there has been an “epidemic” of hepatitis C in the U.S. and the Veterans Administration, alcohol-related liver injury remains a higher cause of mortality. Studies from the Veterans Administration showed that patients with cirrhosis and superimposed alcoholic hepatitis had > 60% mortality over a four-year period of time, with most of those deaths occurring in the first few months. Thus, the prognosis for this stage of ALD is worse than many common types of cancer, such as breast, prostate and colon. Unfortunately, there is no FDA-approved therapy for any stage of ALD, and this makes the need for this proposed research even more compelling. The proposed studies will help to better understand the molecular mechanisms of alcohol-induced liver and intestinal injury, including alcohol-diet interactions, which may lead to identification of new therapeutic targets and potential dietary interventions for treating ALD, as well as help to explain why only some heavy drinkers develop clinically important ALD.